Implementing an effective Diabetes intervEntion Among Low-income immigrants (IDEAL Study)

PROJECT SUMMARY
This proposed R18 is in response to the RFA-HS-23-002 Dissemination and Implementation of Equity-Focused
Evidence-Based Interventions in Healthcare Delivery Systems. Chinese immigrants are the second largest
immigrant group in the U.S., who suffer a disproportionately high type 2 diabetes (T2D) burden and have poor
diabetes outcomes. Diabetes Self-Management Education and Support (DSMES) programs are evidence-
based interventions that provide patients with important counseling and support to navigate diabetes self-
management at home. However, numerous social determinants of health (SDOH) barriers limit the
dissemination of DSMES programs to Chinese immigrants, including high rates of poverty, limited English
proficiency (LEP), and lack of access to care and insurance. Given the high T2D burden and rapid population
growth in Chinese immigrants, there is an urgent need for research to disseminate and implement DSMES in
this minority population. The overarching goal for our proposed R18 IDEAL study (Implementing an effective
Diabetes intervEntion Among Low-income immigrants) is to test the effectiveness and implementation process
of an innovative multi-level care model for delivering a culturally tailored diabetes intervention to low-income
Chinese immigrants with diabetes. Building upon our strong pilot data and established partnerships with clinical
and community partners in Chinese immigrant communities, we propose to conduct a type 1 hybrid study to
examine the effectiveness and implementation process of the IDEAL intervention for glycemic control among
270 Chinese immigrants with uncontrolled T2D in NYC. Participants will be randomized with equal allocation to
one of the two groups. The IDEAL group will receive 1 culturally and linguistically tailored DSMES brief
video/week for 24 weeks delivered via text message links plus bi-weekly support calls from a CHW for 24
weeks. The CHW will assess participants’ SDOH barriers to T2D care and link them to available resources in
the community. The wait-list control (hereafter CONTROL) group will continue to receive usual care and at the
end of the study, they will receive DSMES videos. The primary outcome is HbA1c at 6 months and secondary
outcomes include HbA1c at 12 months and psychosocial factors at 6 and 12 months. This study addresses the
urgent need to disseminate and implement evidence-based diabetes interventions in underserved populations
to reduce health disparities. Study findings will provide important evidence on potential scalable strategies to
foster the dissemination of effective implementation, replication, and sustainability of evidence-based
interventions for use in healthcare and community settings. It can also serve as a program model for other high
risk LEP immigrant populations such as Hispanic immigrants who also bear a high T2D burden, face similar
SDOH barriers to accessing DSMES programs, and frequently use text messages.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCY STATEMENT) Chinese immigrants suffer a disproportionately high type 2 diabetes (T2D) burden and have poor health outcomes. They face numerous social determinants barriers to accessing evidence-based diabetes programs, including high rates of poverty and limited English proficiency (LEP), and lack of insurance. This project will provide important evidence on scalable strategies to disseminate and implement evidence-based diabetes interventions in LEP Chinese immigrants with T2D.